CONSTRUCTION OF PSYCHOLOGY RESEARCH BUILDING

The purpose of this application is to request NCRR matching funds for the construction of a state-of-the-art research and training facility for the Psychology Department of Tufts University. The Psychology Department has 13 researchers engaged in a variety of collaborative bio-behavioral research endeavors focused on basic and clinical research questions in biological, cognitive and social psychology. These researchers have vibrant, well funded and growing research programs addressing important mental health issues including learning disabilities, dug addiction,, nutrition affects on behavior, anxiety disorders, infant motor and social development, mental retardation and social communication. However, their efforts are severely hampered by an aged/inadequate research and administrative facility, no capacity to expand, and by being housed in three by buildings The proposed plan addresses these problems by consolidating the department into two neighboring 21st century research facilities. The new 28,800 square foot Psychology Research Building (for which funds are being requested) will contain laboratories for researchers engaging in human research, for conducting neurochemical and neuroanatomical studies as well as offices for all faculty members, graduate students, post-docs, research staff and administrative staff. The second building, Bacon Hall (for which funds are not being requested), will continued to serve as the primary laboratory facility for faculty members who use experimental animals in their research programs. The consolidation of faculty, students, research and administrative staff into a new building, and the proximity of the two Psychology Department facilities will allow for much greater efficiency as well as future expansion for current and anticipated new faculty.